Microbial Genomics and Analytical Laboratory (MGAL) Core

PROJECT SUMMARY – Microbial Genomics and Analytical Laboratory (MGAL)
The Microbial Genomics and Analytical Laboratory (MGAL) Core of the Integrative Center for Environmental
Microbiomes and Human Health provides a centralized facility and technical expertise at the University of
Hawai‘i at Mānoa (UHM) to support the study of the interface between the microbial environment and human
health. The characterization of microbiota community composition by high throughput sequencing and
metabolite analysis are standard techniques used in the field of microbiome research. The MGAL Core
enables access to these key methods by providing the following: (i) services for the preparation of genomic
libraries and quantification of gene expression; (ii) high-performance liquid chromatography and mass
spectrometry instrumentation for the analysis of lipids and metabolites; and (iii) facilities for the cultivation,
isolation, and long-term storage of microbial strains. To expand Core capabilities and user base while
continuing to support current and past COBRE researchers, MGAL services will be expanded to include
metagenomic and transcriptomic library preparation, metabolomic analysis, and enhanced microbial
biobanking facilities that will include the creation of a community searchable database containing information
about endemic Hawaiian strains. The MGAL Core is available to researchers throughout the state of Hawai'i
and visiting scientists, thus encouraging greater interaction within the local microbiome research community
and seeding collaborative efforts from abroad. The facility will beneficially impact COBRE investigators and
affiliates by providing essential infrastructure and expertise to advance research and foster the careers of
junior faculty. Moreover, the Core will support the continued growth of UHM as a major center for microbiome
studies in the Pacific Region by providing hands-on training in library preparation and metabolite analysis,
hosting summer workshops on fundamental microbiome research methods, integrating with undergraduate and
graduate laboratory classes, and facilitating outreach efforts to characterize Hawai'i’s microbiome.